Burnout Reduction for MH Providers to Improve QOC and Reduce Staff Turnover

DESCRIPTION (provided by applicant): Health care providers, particularly those who work in the mental health field, are at high risk for experiencing burnout - high levels of emotional exhaustion, cynical attitudes towards consumers of services, and a reduced sense of personal accomplishment. Theory and research suggest that as care providers conserve psychological resources to deal with emotional stress, they withdraw and become less engaged in their work, which can have a negative impact on the quality of care provided. Yet, few studies have intervened to reduce mental health worker burnout. We have developed an intervention entitled Burnout Reduction: Enhanced Awareness, Tools, Handouts, and Education (BREATHE) that has shown promising outcomes regarding burnout for mental health providers. This intervention targets the individual provider, focusing on building the individual's resilience and skills. However, research suggests that organizational factors can be powerful predictors of burnout and engagement. Thus, the purpose of this R34 project is to examine the feasibility and preliminary outcomes of integrating an organizational approach to reducing burnout with the BREATHE program. We will use Appreciative Inquiry as both a participatory action research strategy and an organizational change approach to identify what is working well within a community mental health center and to partner with stakeholders in the organization to develop and implement strategies to build on those strengths to enhance worker engagement and reduce burnout. We will combine Appreciative Inquiry with BREATHE in an open trial in six mental health teams using a multiple baseline design with staggered start times. This project is the first important step in addressing a critical need in workforce development that could ultimately address strategic aims of the National Institute of Mental Health in ensuring access to the highest quality and most cost-effective services for consumers with mental illness.

Public health relevance
PUBLIC HEALTH RELEVANCE: Staff burnout is a highly prevalent challenge for healthcare providers, organizations, and the consumers of the healthcare services. This study will develop an organizational approach to reducing staff burnout to complement an existing individual-level intervention. We will evaluate the feasibility and preliminary outcomes of this combined approach to reducing staff burnout and maintaining an effective behavioral health care workforce.